Next Generation Robotic System for Supervised-Autonomous Bowel Anastomosis

Project Summary:
The goal of this project is to establish a new medical robot and surgical paradigm to perform clinical colonic
anastomosis with shared control. We will develop and evaluate novel miniaturized functional 3D imaging, artificial
intelligence (AI) based real time soft tissue tracking, and fail-safe autonomous control strategies that enable first
in human autonomous robotic soft tissue surgery. The long-term goal of this proposal is to reduce the
complication rates and improve functional outcomes of bowel anastomoses and other soft tissue surgeries
independent of surgeon’s experience. Anastomoses are critical and challenging procedures performed over a
million times per year in the US. However, up to 19% of gastrointestinal anastomoses are complicated by
leakage, strictures, and stenosis, and anastomotic complications significantly increase patient mortality up to ten
times. Recent key advances in surgery such as progressively more minimally invasive surgery (MIS) and robot-
assisted surgery (RAS) using a tele-operated da Vinci robot have not addressed the critical factors influencing
anastomotic outcome, and the overall anastomotic complication rates remain unchanged. Autonomous robotic
surgery systems have the potential to significantly improve efficiency, safety, and consistency over current tele-
operated RAS. Autonomous robotic soft tissue surgery is yet to be demonstrated in humans due to a lack of (a)
accurate 3D endoscopic vision, (b) robust markerless soft tissue tracking, and (c) fail safe autonomous control.
To address the clinical need for autonomous robotic suturing platforms, we developed a supervised autonomous
robotic system for guiding reconstructive bowel anastomosis. We propose to conduct first-in-human pilot studies
of an autonomous robotic suturing platform. Because complications from bowel anastomoses can be
catastrophic, we implement a stepwise gradual increase of complexity starting with open overstitching of the
closure of a common enterotomy and building up to laparoscopic colectomy to ensure patient safety. We
hypothesize that autonomous robotic soft tissue surgery is feasible in humans and will perform the task of
laparoscopic colectomy with better accuracy and efficiency over current tele-robotic RAS technology. The
following four specific aims will enable the development of this technology and demonstrate clinical feasibility.
We will develop miniaturized functional 3D imaging and tissue health sensing (Aim 1), AI based markerless
tissue tracking (Aim 2), fail-safe autonomous control strategies (Aim 3), and demonstrate first in human
autonomous soft tissue surgery in the form of common enterotomy closures (Aim 4). Beyond intestinal
anastomosis, adoption of this approach could be beneficial in all soft tissue MIS and RAS tasks requiring
precision and maneuverability, including complex pediatric, urological, and cardiac surgery.

Public health relevance
Project Narrative: The goal of this project is to establish a new medical robot and surgical paradigm to perform clinical colonic anastomosis, a critical and challenging procedure, with shared control. We will develop and evaluate novel miniaturized functional 3D imaging and tissue health sensing, artificial intelligence (AI) based real time soft tissue tracking, and fail-safe autonomous control strategies that enable first in human autonomous robotic soft tissue surgery. The long-term goal of this proposal is to reduce the complication rates and improve functional outcomes of bowel anastomoses and other soft tissue surgeries independent of surgeon’s training, skill, and experience.